Role of SHE and ABL signaling in vascular tubulogenesis

Project Summary
Formation of vascular lumen of appropriate size, or tubulogenesis, is one of critical steps during
vascular development. Many vascular diseases including venous malformations are associated with malformed
or enlarged lumens. However, we still have a limited understanding of molecular events that regulate vascular
lumen size.
Abelson (Abl) kinase signaling regulates diverse processes during development and disease, including
cytoskeletal reorganization required for cell morphogenesis, cell motility, adhesion and polarity. Abl signaling in
different cell types can induce activation of Rho GTPases, which are known key regulators of lumen formation.
However, the role of Abl signaling in regulating vascular lumen size has not been previously investigated.
Src homology 2 domain containing E (She) protein was originally identified as a highly conserved
factor, which interacted with Abl kinase. We have previously demonstrated that She is specifically expressed in
embryonic vasculature in zebrafish embryos. However, its biological function is still unknown in any organism.
Here we obtained preliminary data which argues that She acts as a novel regulator of vascular lumen
size. Zebrafish mutant embryos deficient in she function display enlarged vascular lumen within the dorsal
aorta. Similarly, human vascular endothelial cells, deficient in SHE function, form enlarged tubes. Our
preliminary data further suggest that She functions as a novel regulator of Abl signaling, and argue that ABL
signaling and lumen formation are misregulated in human venous malformation (VM), suggesting a potential
role for ABL and SHE in human disease. We hypothesize that SHE is a novel adaptor protein which functions
in the ABL kinase signaling pathway to restrict lumen size during vascular tubulogenesis. We further
hypothesize that SHE overexpression may reduce lumen size in VM leading to a novel therapeutic approach.
The following specific aims are proposed: 1) Determine the cellular and molecular mechanisms by
which She regulates tubulogenesis; 2) Determine if She restricts lumen size by inhibiting Abl kinase signaling
pathway; 3) Determine if She overexpression can reduce lumen size in VM. Zebrafish embryos deficient in
she function will be analyzed for cellular and molecular defects in vascular tubulogenesis. Conservation of She
function will be tested in human vascular endothelial cells. The role of Abl kinase signaling in tubulogenesis
and its interaction with She will be analyzed using chemical inhibitors, genetic mutants and biochemical assays
in zebrafish embryos and human cells. The therapeutic potential of SHE to reduce the size of vascular lumen
will be analyzed in the cell culture and mouse VM model as well as in primary cells isolated from VM patients.
Obtained results will identify the role for SHE and ABL signaling during normal and pathological tubulogenesis,
which may lead to the development of novel strategies to treat vascular malformations.

Public health relevance
Project Narrative Molecular and cellular mechamisms that regulate the formation and maintenance of vascular lumen, or tubulogenesis, are poorly understood. The proposed study will investigate the functional role of an evolutionarily conserved novel adaptor protein Src homology 2 domain containing E (She) and its interaction with Abelson (Abl) kinase signaling pathway in regulating vascular lumen size in zebrafish embryos and human vascular endothelial cells. We will further explore the potential application of SHE as a tool to normalize vascular lumen size in human venous malformation. The acquired knowledge will promote development of new strategies aimed at treating vascular malformations as well as bioengineering new vessels for regenerative therapies.